MB-SWIFT as a novel approach for simultaneous functional imaging of the brain and spinal cord

ABSTRACT
Our goal is to establish a novel MRI approach to acquire functional MRI (fMRI) data simultaneously from brain
and spinal cord. Unlike standard MRI readouts, our approach does not require a dedicated shimming procedure,
as it is based on the newly developed zero echo time MRI pulse sequence entitled Multi-Band SWeep Imaging
with Fourier Transformation (MB-SWIFT) which is inherently resilient to magnetic field inhomogeneities.
Comprehensive evaluations of the central nervous system (CNS) function will tremendously benefit from this
imaging modality, particularly in areas of research such as spinal cord injury, neurodegenerative diseases, pain
and aging. Thus far, functional neuroimaging of the CNS has been an untapped area of research due to several
technical challenges, the biggest of which is the need to efficiently shim a field of view large enough to cover
both brain and spinal cord. Solutions of per-slice dynamic shimming approaches have been proposed. However,
they are limited by the settling-time of eddy currents, they considerably prolong the experimental session, and
they have been applied only to cover cervical (but not lower) spinal cord. Furthermore, dynamic shimming allows
only inefficient sequential rather than simultaneous acquisitions of brain and spinal cord, posing additional
challenges for CNS fMRI. As proven by our preliminary data, MB-SWIFT can instead image two fields of view
(FOVs) at distant locations in brain and lumbar spinal cord in a true simultaneous fashion (i.e., within 1 ms of
each other), thus allowing unprecedented functional imaging of the CNS that is unattainable with standard
imaging modalities for fMRI. The current project is a proof-of-concept study conducted in rats, designed to first
optimize the MB-SWIFT protocol including the dual RF coil and the dual FOV acquisition, then to demonstrate
that fMRI of CNS with MB-SWIFT provides robust fMRI outcomes in absence of dedicated shimming solutions.
Moreover, we will optimize spoke order of MB-SWIFT and post-processing pipeline for handling physiological
noise, and demonstrate that MB-SWIFT provides surrogate markers of neuronal activity in spinal cord. Finally
we will establish inter-subject, intra-subject and inter-site reproducibility of task-based and resting-state fMRI
outcomes extracted from the CNS with dual FOV MB-SWIFT. Once completed, the study will provide an
invaluable tool for pre-clinical research, and will set the stage for translation to humans.

Public health relevance
PROJECT NARRATIVE Current functional neuroimaging studies target either the brain or the spinal cord, but usually not both at the same time because simultaneous acquisitions from brain and spinal cord are challenged by several obstacles posed by conventional MRI modalities. In this project we will exploit a novel MRI pulse sequence entitled Multi- Band SWeep Imaging with Fourier Transformation (MB-SWIFT) that overcomes such challenges and will allow for the first time simultaneous fMRI of brain and spinal cord. The proposed study will prove that MB-SWIFT is a transformative approach for conducting unprecedented investigations of the central nervous system, crucial for advancing knowledge in several areas of research including spinal cord injury, neurodegenerative diseases, pain and aging.